Positive Activities for Asian American Cancer Patients and Caregivers

PROJECT SUMMARY/ABSTRACT
Asian Americans (AAs) are the fastest growing minority group in the U.S., and cancer is the leading cause of
death among this group. Although AA who are diagnosed with cancer commonly report fear, distress, and
depression, they have been found to utilize mental health services at lower rates than other groups and this
may be due to a dearth of culturally-competent services. Prior research on these cancer patients’ lives has
focused on barriers associated with health literacy and language proficiency but has ignored unique culture-
related challenges that contribute to their poor emotional outcomes. AAs are members of collectivist cultures
who view themselves as connected, relational, and belonging to a larger social group. Following changes in
physical function and social roles and responsibilities (e.g., job loss) after a cancer diagnosis, individuals may
self-perceive that they are a burden on their family members/caregivers. Therefore, the overarching goal of the
current proposal is to reduce the burden AA patients may feel they are on their caregivers by designing and
testing the feasibility of two positive activity interventions. We expect that contributing to one’s household and
outside one’s home will increase health-related quality of life (HRQOL) in AA cancer patients by increasing a
sense of relatedness, autonomy, and competence (mediators). In the K99 phase, 30 AAs ages 25-70 and
within 1 year of any cancer diagnosis will engage in either: 1) household contribution; 2) outside contribution;
or 3) control activities. Quantitative and qualitative (e.g., semi-structured interview, project personnel work logs)
data about the successful elements of the interventions will be collected. In collaboration with the mentorship
team, AA community members, and clinicians, a prototype of one or both positive activity interventions
(household or outside contribution) will be developed for AA cancer patients. In the R00 phase, 118 patients
(same inclusion criteria as K99 phase) will be randomized to either the contribution or control group. They will
engage in the positive or control activity once per week for 3 months, and outcomes and mediators will be
assessed at baseline, 1.5 months (midpoint), 3 months (post-test), and 6 months (follow-up). The trial will: 1)
assess the feasibility and acceptability of the household and outside contribution positive activities, 2) develop
a prototype of a positive activity intervention (household or outside contribution) for AA cancer patients, 3)
assess changes in HRQOL comparing intervention to control patients, and 4) assess mediators of the
intervention effects. This proposal introduces a novel, low cost, not stigmatizing, easy to implement, and highly
scalable approach not previously tested in AA cancer patients: engaging in positive activities. If found to be
successful, this framework for understanding patient-caregiver relationships in AAs can be used to develop
other positive activities that will improve and extend the lives of cancer patients from other collectivist cultures.
The proposed training plan will be critical in expediting the candidate’s transition into an independent
investigator with focused expertise in developing positive activities to eliminate cancer care disparities in AAs.

Public health relevance
PROJECT NARRATIVE Following changes in physical function and social roles and responsibilities after a cancer diagnosis, Asian Americans may self-perceive that they are a burden on family members, which is related to a lower quality of life and more distress and depression. Despite this, Asian American cancer patients utilize mental health services at lower rates than other groups and this may be due to a dearth of culturally-competent services. The goal of the project is to design and test the feasibility of two positive activity interventions, household contribution and outside contribution, intended to increase health-related quality of life in Asian American cancer patients by increasing a sense of relatedness, autonomy, and competence.